Project 3: Characterization of Beta-Catenin Degraders for the Treatment of Colorectal Cancer

PROJECT SUMMARY/ABSTRACT: Project 3
The long-term objective of this study is to investigate how a new class of compounds, β-catenin degraders, can
be exploited to target Wnt/β-catenin (henceforth Wnt)-driven colorectal cancers (CRCs). Aberrant activation of
the Wnt pathway drives the initiation and progression of nearly all CRCs. To date, no drugs inhibiting the Wnt
pathway have been FDA-approved due to a lack of druggable targets that can bypass common Wnt pathway
mutations in CRC. In a conceptual breakthrough, using an NMR-based fragment screen followed by X-ray guided
medicinal chemistry with support from NCI’s Chemical Biology Consortium, we have discovered small molecules
that bind with nanomolar affinity to β-catenin, the central regulator of the Wnt pathway. These compounds were
used to create chimeric small molecule-based PROTACs that degrade β-catenin in CRC cells with pathway-
activating mutations. We have shown that β-catenin degradation occurs via the ubiquitin-proteasome pathway
and that the PROTAC degraders can inhibit the expression of Wnt target genes. Furthermore, this class of
compounds inhibits the growth of both CRC cells and spheroids from a β-catenin mutant CRC cell line. These
highly potent PROTACs also degraded β-catenin and inhibited Wnt pathway signaling in vivo, using CRC cell
line xenografts in nude mice. We thus demonstrate that β-catenin PROTACs may provide a new means for
controlling aberrant Wnt signaling and lay a foundation for the discovery of a novel treatment for nearly all CRCs.
This project aims to use cutting-edge sophisticated in vitro, ex vivo, and in vivo approaches to better understand
the effects of β-catenin degradation in CRC, thereby enabling their clinical translation. We propose to
characterize the mechanism of action of the β-catenin PROTACs in CRC, determine the therapeutic window and
potential toxicities associated with β-catenin degradation, and provide proof of principle for the effectiveness of
β-catenin PROTACs in CRC patient-derived organoids (PDOs), CRC cell line xenografts, and a stem cell-driven
mouse model of colorectal neoplasia. We propose three specific aims: 1) test the sensitivity of CRC cell
monolayers and spheroids to β-catenin PROTACs; 2) determine the extent of PROTAC-induced degradation of
E-cadherin-associated β-catenin; and 3) examine the effects of PROTACs in CRC cell line xenografts and
Lrig1CreERT2;Apcflox/+ mice. At the end of this funding period, we will have fully characterized high-quality β-catenin
PROTAC drug candidates, enabling their progression to IND-enabling studies.

Public health relevance
PROJECT NARRATIVE: Project 3 The most common initiating event in colorectal carcinogenesis, the second leading cause of U.S. cancer-related death, is activation of the Wnt signaling pathway. The goal of this study is to discover and characterize the first successful Wnt inhibitor by degrading β-catenin, the linchpin of the Wnt pathway, and to understand the biology and mechanism of this novel class of drugs. The results from this study will inform us of the effectiveness, toxicity, and patient population that can be treated with β-catenin degraders, ultimately resulting in submission of an Investigational New Drug application for the treatment of colorectal cancer.